Lymphangiogenesis in the pathogenesis of acute kidney injury

Project Summary
Acute kidney injury (AKI) is a common and serious complication of medical and surgical diseases that
has significant attributable morbidity and mortality in critically ill Veterans. Analysis of Veterans Health
Administrative data reported that Veterans who develop AKI during a hospitalization are at substantial risk for
the development of chronic kidney disease (CKD) within 1 year. AKI is also a major complication of
hospitalized COVID-19 patients and almost half of these patients who develop AKI do not recover to baseline
kidney function. Numerous therapeutic interventions have been evaluated in clinical trials to overcome this
significant clinical challenge, with none proven successful. The overall goal of this proposal is to fill this gap
in knowledge by discovering new targets that could be exploited for therapeutic interventions in AKI.
The focus of this project on the lymphatic system, specifically lymphangiogenesis in the kidney, will
build upon the progress made during the previous funding cycle. Lymphatics aid in transport of inflammatory
cells, removal of cellular debris from the microenvironment of inflammation-induced injury, drainage of excess
fluid and ultimately facilitate tissue repair. While studies have highlighted the key role for lymphangiogenesis
in the heart, the role of the lymphatic system in the kidney in the pathogenesis of AKI and the AKI to CKD
transition is only now being recognized.
Our recently work demonstrated that VEGF-C and VEGF-D, the major ligands in lymphangiogenesis,
are abundantly present in renal tubules at baseline and are secreted following injury. Lymphatic vessel
formation is robustly induced following kidney injury in multiple models of AKI. Our central hypothesis is that
inflammation associated lymphangiogenesis is beneficial in the pathogenesis of AKI and the transition of AKI
to CKD. We will test this overall hypothesis in three aims. In Aim 1, we will test the hypothesis that
inflammation associated lymphangiogenesis originates from preexisting lymphatic endothelial cells in the
kidney after AKI. In Aim 2, we will test the hypothesis that an intact lymphatic network maintained by myeloid
lineage cells is required for preserving renal structure and function after AKI. In Aim 3, we will test the
hypothesis that LA is dependent on NF-κB expression in lymphatic endothelial cells following AKI and during
the AKI to CKD transition.
These studies will have a significant impact both in uncovering mechanisms of lymphangiogenesis
and providing new insights into the dynamic function of lymphatics in the pathobiology of AKI. Upon successful
completion of the proposed aims, we will have comprehensively examined the role of lymphangiogenesis in
AKI and the AKI to CKD transition, and will also provide a novel platform that will facilitate translational
therapeutic efforts in the field.

Public health relevance
Project Narrative Acute kidney injury (AKI) is a common and serious complication in hospitalized Veterans. Patients with AKI are at significant risk for the subsequent development of chronic kidney disease (CKD). This proposal will focus on the lymphatic system, which is crucial for maintaining fluid balance, transporting lipids, and aiding in immune function, within the kidney particularly during AKI and the AKI to CKD transition. Successful completion of the aims of this project will help better understand the pathogenesis of AKI during both injury and repair and could provide new avenues targeting the lymphatic system for therapeutic interventions in AKI.